Glial metabolic status regulates axon regeneration in the central nervous system

PROJECT SUMMARY
Neuronal or axonal damage in the central nervous system (CNS), caused by injury or diseases, is irreversible
and may lead to persistent neurological deficits. Spinal cord injury (SCI) often causes severe sensory and motor
dysfunction and paralysis. Of approximately 1.9% of the U.S. population living with paralysis, over 1,275,000 are
paralyzed as the result of SCI. Currently, there is still no cure for the injured spinal cord itself, emphasizing the
desperate need to identify novel pathways for targeted therapy.
Regarded as the holy grail in regenerative medicine, achieving axon regeneration and functional recovery after
CNS injury or in neurodegenerative diseases remains a daunting task. The inability of CNS axons to regenerate
after injury is attributed to the reduced intrinsic growth capacity of neurons and the inhibitory milieu largely
constituted by the reactive glial cells. It is conventionally thought that the structural formation of glial scar and its
upregulation of the repulsive CSPGs are the main culprit leading to stalled regrowth. However, accumulating
evidence in the past decade has demonstrated that preventing astroglial scar formation following CNS injury
does not result in increased regrowth. It is proposed that glial scar is important in preserving tissue integrity and
mitigating further inflammatory damage. Glial scar may have beneficial effects during the acute phase of injury,
but prevents axon regrowth in the chronic or later stages. In our latest work, via glia-specific metabolic
reprogramming, we succeeded in mitigating their adverse effects while enriching their promotive functions. We
demonstrated that glial reprogramming enhances glial glycolysis, and the production and release of metabolites
– lactate and L-2HG, which act through neuronal GABABRs to boost axon regeneration. However, major gaps
remain: are lactate and L-2HG the only pro-regeneration metabolites; do anti-regeneration metabolites also exist;
do glia subtypes behave similarly after metabolic reprogramming. Our published work allows us to ask the
essential question: does metabolic status dictate glia’s ability to promote or inhibit CNS axon regeneration? This
would have a fundamental impact on our understanding of axon regeneration, as it applies to all species across
the evolution spectrum. An equally intriguing question is: does the metabolic status differ between regeneration
competent and incompetent CNS neurons? Our proposal aims to answer these questions, and test our
hypothesis that glial and neuronal metabolic status governs the regeneration capacity of CNS neurons.
Although various strategies to boost the neuronal intrinsic regenerative ability, to remove the extrinsic inhibitory
factors such as CSPGs, to transdifferentiate glia into neurons, or to transplant stem cells into CNS have been
reported, none of them have translated into clinical use. There is still a pressing need for new concepts to
promote CNS axon regeneration. Our pilot results demonstrate that the state of glial cells that promotes axon
regeneration can be achieved by reprogramming. This project aims to uncover metabolic enzymes as therapeutic
targets, and metabolites or their derivatives as potential pharmacological agents for treating CNS injury.

Public health relevance
PROJECT NARRATIVE Central nervous system (CNS) injury such as spinal cord injury (SCI) is refractory to repair, attributed to the reduced neuronal intrinsic regeneration capacity and an inhibitory microenvironment largely constituted by the reactive glial cells. Understanding the mechanisms that inhibit or promote neural regeneration is relevant to public health because it may ultimately lead to treatments for neural injury and neurological diseases. Our study demonstrates that reprograming the reactive glial cells via metabolic rewiring promotes CNS axon regeneration and functional recovery, providing a new concept for treating CNS injuries such SCI.